Training in Theory and Computation for Next Generation Neuroscientists

Training in Theory and Computation for Next Generation Neuroscientists
Project Summary
To understand the function and dysfunction of the brain it is necessary to confront its complexity. Over the past
two decades the ﬁeld of neuroscience has leveraged the tremendous advances in electronics, genetics, and
microscopy to collect a bewildering amount of neuronal data, especially when compared to the state of the ﬁeld
at the turn of the last century. More than ever these datasets require sophisticated analysis techniques to expose
the salient aspects of brain dynamics and computation. Of equal importance is building a coherent theory of
brain function. Theory can both organize these datasets under a conceptual umbrella, as well as suggest the
next series of experiments to be performed. These realities require more neuroscience researchers to be trained
in a variety of computational and mathematical techniques. This project outlines an ambitious graduate and
undergraduate Training Program in Computational Neuroscience (TPCN) at the University of Chicago.
The University of Chicago TPCN has 31 training faculty distributed over 10 departments. The training faculty
are composed of 6 faculty in computational neuroscience (dry-lab), 9 training faculty whose laboratories are
primarily experimental, and 15 training faculty whose laboratories are both computational and experimental. At
the graduate level the TPCN offers a PhD program in Computational Neuroscience and a complementary PhD
program in Neurobiology. At the undergraduate level the University of Chicago has a highly popular Major in
Neuroscience, and students can Minor in Computational Neuroscience. The TPCN is set within a highly collegial,
cross-disciplinary environment of our Neuroscience Institute and the Grossman Center for Quantitative Biology
and Human Behavior. The Neuroscience Institute was established in 2014 to foster interdisciplinary research on
the neural mechanisms of brain function, and now comprises 87 faculty having appointments in 16 departments.
The Grossman Center was launched in 2020 and is a space within the Neuroscience Institute with an explicit
focus on computational and theoretical neuroscience. Over the next ﬁve years the Grossman Center will grow
to house 5 computational neuroscience faculty to complement our already existing community of theoretical
neuroscientists. During this funding period the TPCN will (1) strengthen the course offerings in computational
neuroscience at both the graduate and undergraduate level; (2) create a undergraduate research program in
computational neuroscience; (3) enhance our minority recruitment by taking advantage of the undergraduate
neuroscience research program.
TPCN trainees work in vertically integrated, cross-disciplinary research teams. Graduate students take a se-
ries of directed courses in computational neuroscience that span both statistical and modeling approaches. To
ensure their competency in core neuroscience principles they also take courses in cellular, systems, and behav-
ioral neuroscience. Their training will be supplemented with courses in a relevant quantitative discipline, such as
computer science, engineering, mathematics, or statistics. All graduate students will have extended experience
in at least one experimental laboratory, and they take part in journal clubs and seminars within the University
of Chicago Neuroscience community. Supported undergraduates take courses in mathematics, computer pro-
gramming, statistics, and neuroscience; they take an additional course in neuroscience or psychology and two
courses in Computational Neuroscience; and they complete a research project. In addition, they complete the
TPCN summer program. Undergraduate trainees in the summer program go through the boot camp on topics in
computational neuroscience, including tutorials in Matlab, statistical methods, fundamentals of differential equa-
tions, and ideas of neural coding; they then complete a research project under careful guidance. All trainees
will receive training in responsible conduct of research. Across 5 years of funding, the TPCN supports 20 NRSA
graduate students, 10 non-NRSA graduate students, 30 undergraduate school-year and 30 summer fellows.

Public health relevance
Project Narrative The ﬁeld of neuroscience is experiencing a renaissance in terms of the scale and complexity of the datasets that are now routinely collected. It is crucial that the next generation of neuroscientists are able to synthesize, organize, and model these datasets, with the goal of building new theories of the brain. The central goal of our training program will be to train the next generation of neuroscientists with the strong quantitative skills needed to advance the ﬁeld.